Mechanisms of Aging Regulation by Neuronal mTORC1 in C. elegans

PROJECT SUMMARY
Aging is the major risk factor for multiple chronic diseases and two-thirds of individuals over the age of 65
suffer from multiple age-related conditions. Rather than trying to cure each individual disease, healthy aging
can be promoted by targeting the biological pathways that regulate the rate of aging. The mTORC1
(mechanistic target of rapamycin complex I) signaling pathway promotes cellular growth and development
when nutrients are abundant and its inhibition extends lifespan in a range of species. However, the promise of
mTORC1 inhibition as an anti-aging therapeutic is limited by the associated negative side effects such as
stunted growth, development, and fertility. The overarching goal of this project is to understand the
mechanisms and key tissues through which mTORC1 specifically regulates aging in an effort to
identify ways to target the mTORC1 pathway that can uncouple longevity from adverse health effects.
Previous work in C. elegans found evidence that mTORC1 regulates aging through the neurons. In a long-lived
mutant with decreased mTORC1 signaling throughout its entire body, restoring mTORC1 signaling only in the
neurons suppressed the lifespan back to wild type. However, this neuronal mTORC1 rescue had no effect on
the impaired growth or development of the null mutant, suggesting that targeting mTORC1 in key tissues may
be a strategy to uncouple aging regulation form other mTORC1 functions. Lastly, this work found that restoring
neuronal mTORC1 signaling induced changes in the expression of multiple neuropeptide genes and altered
the shape of the mitochondrial network in peripheral tissues. Building on these findings, we have recently
generated new data showing that neuron-specific mTORC1 inhibition in C. elegans extends lifespan without
impairing growth or development. Thus, the central hypothesis of this proposal is that mTORC1 regulates
aging, independently of other functions, through the neurons by modulating neuronal signaling and
inducing metabolic changes cell-nonautonomously in peripheral tissues. We will use a suite of tissue-
specific tools to investigate this hypothesis and probe the mechanisms of aging regulation by mTORC1 with
unprecedented specificity. In Aim 1, we will assess how neuronal mTORC1 inhibition affects phenotypes
associated with whole-body mTORC1 inhibition – such as growth, development, reproduction, and stress
resistance – and test whether there are changes to the mitochondrial network in peripheral tissues. We will
also identify downstream biological pathways that are required for neuronal mTORC1 longevity. In Aim 2, we
will identify the specific neuronal signaling molecules and types of neurons through which mTORC1 acts to
regulate aging. Altogether, this work will deepen our understanding of how metabolic pathways regulate aging
and allow us to design strategies to target these pathways in a manner that promotes healthy longevity.

Public health relevance
PROJECT NARRATIVE The metabolic sensor mTORC1 has been successfully targeted to promote longevity in a range of species, but the translational capacity of this anti-aging intervention to humans is limited by negative side effects and a lack of knowledge about the mechanisms driving lifespan extension. The goal of this project is to investigate how neuron-specific mTORC1 inhibition in C. elegans extends lifespan without impairing growth or development by assessing changes both in the neurons and in peripheral tissues. This work will advance our understanding of both the metabolic regulation of aging and the functions of the mTORC1 pathway in general, and will influence the way we design interventions to promote healthy aging.